Decoding epigenetic adapters of cell state

PROJECT SUMMARY/ABSTRACT
Pluripotency is a fleeting state in the embryo that is the source for all the cell types of the body. This
enormous developmental potential is facilitated by a permissive genome structure globally depleted for the
nucleosomal compaction and heterochromatin that direct lineage acquisition. Amazingly, embryonic stem cells
(ESCs) derived from the inner cell mass capture the pluripotent state and its specialized chromatin signature in
vitro. As expected, ESCs are enriched for activating histone lysine acetylations, but surprisingly are the most
depleted for modifications associated with ongoing transcription found at gene bodies. The epigenome is
causal in developmental potential as maintenance of pluripotency-associated modifications inhibits their
differentiation and removal of somatic-associated modifications enhances reprogramming to induced
pluripotent stem cells (iPSCs). Therefore, dynamic cell state transitions are a powerful platform that will be
used mechanistically interrogate the epigenetic contribution to cellular identity. In both the embryo and in
ESCs, the global depletion of heterochromatin permits widespread amplification of transcription, despite the
near absence of transcription-associated gene body epigenetic modifications. The relative increase in
transcriptional output was recently observed in adult stem cells and cancer stem cells, but the connection of
developmental potential and the calibration of RNA output is currently unknown. The goal of this research
program is to parse the interconnected network of cellular identity, the epigenome, and the global
transcriptome. To identify how transcription is amplified, we will examine the regulation of RNA polymerase II
checkpoints across cell states. We will define how gene body modifications that enforce the somatic fate
regulate transcriptional output using specialized genetic depletion and targeting tools. We will uncover how
ESCs interpret their uniquely high levels of histone acetylation to sustain pluripotency. Using acute degradation
technologies, we will interrogate how acetylation directs RNA polymerase II across early developmental stages
when transcription commences. The findings of our proposed studies extend to regenerative medicine and
cancer biology as transcriptional output is a scalable feature of developmental potential across tissue type and
cellular identity.

Public health relevance
PROJECT NARRATIVE Pluripotent stem cells have the amazing potential to differentiate into any somatic cell type enabled by an open chromatin structure. The absence of cell identity-enforcing heterochromatin amplifies transcriptional output, a phenomenon broadly observed in lineage stem cells and cancer stem cells. We will develop a research program that mechanistically interrogates the interconnected network of epigenetic modifications, global transcription, and developmental potential across cell states.